Wake Forest University Vesicant Exposure Resource and Coordination Core

Project Summary – Coordination Core. The Coordination Core (CC) of the Wake Forest University Vesicant
ExRC plays an integral role in Vesicant ExRC operations as the primary interface between the Vesicant ExRC
and the CCRP community. By leveraging the technical expertise of the Wake Forest Information Technology
Service and enterprise-level website and data transfer tools, in conjunction with dedicated access to a high-
performance computing environment, the CC will establish a facile environment for streamlined training,
communication and data exchange among Vesicant ExRC members, NIH program managers, and CCRP
collaborators. The CC will be managed by a PhD-level or DVM-level scientist who will be supported by a
technician proficient in online services. The functions of the CC are summarized through four specific aims: 1)
advance vesicant research by providing an open, accessible online Portal for all stakeholders; 2) schedule
collaborative studies with approved investigators; 3) provide a responsive interface between the Vesicant ExRC
leadership and current and potential collaborators; and 4) prepare and submit final study reports and
experimental results to collaborators through a secure link. Overall, the CC has essential roles in marketing, pre-
study planning and coordination and post-study closure. By implementing these aims, the CC will streamline
Vesicant ExRC operations, improve collaborator satisfaction and increase community engagement. The
emphasis on open, reliable and transparent communications will increase the value of the Vesicant ExRC,
enhancing the brand and developing an enthusiastic customer base that will support the eventual transition to a
self-sustaining resource.